Investigator Development Core

Abstract
At Morehouse School of Medicine (MSM) investigator development continues to be integral to
capacity building in biomedical/behavioral/health disparities research. A diverse group of
institutes, departments, and centers offer a varied pool of investigators requesting support for
both scientific and career development. IDC-supported investigators through rigorous
mentoring, support groups, and grant writing workshops, while executing their research projects.
The IDC received a total of 23 proposals and six 2-year pilots were awarded. The PIs of the
awarded pilot projects regularly communicated with the IDC to report project progress in
biweekly meetings. During COVID-19, the progress of pilot project activities and specifically, the
community-driven pilots was impeded. Changes in social distancing and shifts were also
implemented for lab-based studies. A support group was created for pilot awardees to navigate
their research through the pandemic. In total, the pilot program infrastructure was utilized to
collaborate with other MSM programs to develop, award, and sustain a total of 30 small
research projects (6 CTRHD-funded and 24 non-CTRHD seed grants) and associated
mentoring activities to 36 MSM investigators. MSM continues to employ a strong pool of junior
faculty/scientists who can be targeted for development into biomedical/behavioral researchers in
health disparities. In the RCMI Center for Health Disparities Research’s Investigator
Development Core (IDC), we will implement the following specific aims (SA): SA1: Administer
and employ a rigorous and competitive pilot project program to stimulate new biomedical and
behavioral health disparity (HD) research at MSM; and SA2: Provide mentoring and
professional development support for MSM faculty to develop as biomedical and behavioral
population health HD researchers. The two specific aims are also designed to cultivate the
development of research teams focusing on minority health and associated disparities. Hence,
the success of the IDC will have a huge impact on research capacity at MSM and health
disparities nationwide in both urban and rural communities.